CYTOKINE REGULATION IN ANIMALS INFECTED WITH HISTOPLASMA CAPSULATUM

The purpose of this work is to understand the mechanisms involved in developing an effective immune response to a lethal infection with the fungi, Histoplasma capsulatum (H. Capsulatum). In addition, it is also our intent to develop experimental murine models of histoplasmosis in immunocompromised mice to study novel treatment regimens that might be effective in treating disseminated histoplasmosis infection in humans. Primary infection to H. Capsullatum often results in a self limited upper respiratory infection in humans; however, in immunocompromised hosts, diseminated infection can occur through reactivation of a previous infection. Since disseminated histoplasmosis has emerged as a difficult clinical entity in individuals infected with HIV, it was of interest to study the factors involved in maintaining an effective memory immune response. To this end, it was important to first establish a through understanding of the factors which regulate effective primary immunity. In this regard, previous work in this laboratory has shown in a murine model of disseminated histoplasmosis that IL-12, IFNg or TNFa were important factors in mediating primary protection. These studies were extended to study the role that these and additional factors such as nitric oxide and neutrophils had in maintaining an effective immune response following a secondary challenge with H. Capsulatum. A second series of studies were initiated in immunodeficient SCID mice to determine if infected mice could be treated with combination cytokine therapy and chemotherapy. The work involved in this project entails infection of both normal and immunocompromised mice with varying doses of H. Capsulatum. At the time of infection, mice are segregated into various groups are treated with neutralizing antibodies against a range of cytokines (i.e. IL-12, IFNg, or TNFa) or depleted of specific cell types (i.e. T cells or neutrophils) to determine their importance in providing effective immunity. A protective response is assessed by mortality and a determination of the H. Capsulatum burden from liver or spleen cells as determined by quantitative culture. In addition, PCR and cytokine specific ELISA are done from spleen cells to determine the mechanism by which a protective response is achieved and maintained.